Developing a quantitative ultrasound breast scanner for identifying early response of breast cancer to chemotherapy

PROJECT SUMMARY
In this proposal, we will develop new images modes on the QT Ultrasound® tomographic breast scanner and
demonstrate that the scanner with the new image modes can accurately identify the response of breast cancer
patients to chemotherapy. A poorly met clinical need in breast cancer therapy is providing inexpensive and
accurate ways to identify patient responses to chemotherapy early during the course of therapy. For many breast
cancers, lack of patient response to initial therapy is predictive of poor outcome, whereas pathological complete
response strongly correlates with extended survival. Conventional clinical surrogates of response based on
anatomical information such as physical assessments, mammography and standard clinical ultrasound provide
poor early assessments of treatment response. We demonstrated that quantitative analysis of ultrasound
backscatter (QUSB) using conventional hand-held clinical scanners can provide promising metrics of response
of breast cancer to neoadjuvant chemotherapy (NAC/AC) within one week of therapy initiation. These QUSB
results would benefit greatly from improved volumetric accuracy that conventional scanning platforms do not
support, such as transmission and attenuation losses in the signals.
We propose to solve these issues by integrating QUSB with the newly available QT Ultrasound® breast
scanner. This FDA cleared and marketed scanner delivers 3D quantitative images of the breast including sound
speed, (SOS) reflectivity (R) and attenuation (A) values. The QT Ultrasound® breast scanner corrects refractive
and interface attenuation losses. It also provides compounding of multiple angles of view that will further improve
QUSB variance. The scanner’s parameters of SOS, R, A, and mm3 volume measuring accuracy provide
supplementary quantitative features likely to contribute robustness to early identification of response.
We believe that the QUSB+QT Ultrasound® breast scanner can identify response at a level better than MRI.
Even if response identification is only comparable, QUSB+QT Ultrasound® savings in costs, ease of use,
noninvasive native contrast, and patient acceptance would markedly simplify management of breast cancer
therapy and deliver considerable practical advantage and increased accuracy. Therefore, our scientific premise
is that QUSB integrated on the QT Ultrasound® breast scanner will provide improved identification of early
response of breast cancer patients to NAC. Our preliminary data demonstrate that QUSB techniques can identify
nonresponders and predict patient outcomes. Our preliminary results also demonstrate that QUSB techniques
integrate with the QT Ultrasound® platform and benefit from improved QUSB bias and variance. Therefore, the
proposal consists of three aims. The first specific aim is to implement, test and validate QUSB techniques on the
latest QT Ultrasound® breast scanner for clinical data acquisition. The second specific aim is to quantify the
capacity of QUSB+QT Ultrasound® quantitative data to identify nonresponders. The final specific aim is to
quantify the capacity of QUSB+QT Ultrasound® quantitative data to predict patient outcomes.

Public health relevance
PROJECT NARRATIVE Our purpose is to develop a clinical, inexpensive, safe (no ionizing radiation), high resolution, quantitatively accurate breast cancer scanner to address the issue of early identification of breast cancer patients to neoadjuvant chemotherapy. We propose to unite two advanced ultrasound technologies: 1) quantitative transmission ultrasound tomography (QTUS) and 2) Quantitative ultrasound (QUSB) backscatter analysis, the first of which is FDA cleared, into a single device to detect and monitor cancer and its treatment as effectively as MRI and CT without the concomitant danger from radiation or contrast agents. This technology is inexpensive and accurate and addresses the personalized medicine initiative, because it gives quantitative tissue information at the sub-mm level and early feedback on neo-adjuvant cancer therapy for the individual patient.